ANIMAL RESOURCES DIAGNOSTIC AND INVESTIGATIVE LABORATORY

The specific aims of this proposal are: 1) to continue to operate and expand the services of the diagnostic laboratory to support programs of health assessment, diagnosis and control and prevention of diseases of laboratory animals; 2) to develop and/or apply new methods for the detection and prevention of diseases of experimental animals which interfere with research; 3) to recognize and characterize diseases of animals which are potential models of human disease; 4) to conduct research to characterize infectious and noninfectious diseases of laboratory animals, to elucidate pathogenesis, and to develop appropriate treatment, control and prevention methods; and 5) to develop and improve a resource of animal disease material for teaching comparative medicine and pathology. Our methods to accomplish these goals include improving our health care and diagnostic laboratory support programs and expanding research endeavors in comparative medicine and pathology. Ultimately, our purpose is to provide the total spectrum of animal care and support required to present UTHSCD investigators with healthy, characterized animals for their research program and to maintain them in a manner that promotes stability and well being.